Evolved cefiderocol resistance and cross protection

PROJECT SUMMARY/ABSTRACT
Pseudomonas aeruginosa (PA) causes lung infections in 44% of the ~31,000 people in the USA with cystic
fibrosis (CF). PA CF lung infections can last decades because PA mutates and becomes antibiotic resistant.
Antibiotic resistant PA lead to longer hospital stays, higher healthcare costs, and higher mortality rates.
Cefiderocol is a new antibiotic approved for the treatment of multidrug resistant infections. Cefiderocol is highly
potent because it acts as a trojan-horse: entering bacterial cells through iron-binding siderophore activity and
then killing bacteria through inhibition of cell wall synthesis via its cephalosporin antibiotic activity. While highly
effective, in some cases cefiderocol has failed during compassionate use treatment of people with CF. Recently
we used laboratory experimental evolution to discover 20 different gene mutations in PA that conferred
cefiderocol resistance. Among these, cpxS mutations found in >70% of cefiderocol resistant evolved PA also
enabled resistant PA to cross-protect susceptible siblings from cefiderocol killing. Notably, cross-protection acted
through a novel mechanism that did not involve cefiderocol degradation, but instead was mediated by CPX two-
component sensor mutations which led to increased pyoverdine siderophore secretion. Further investigation
showed that two PA siderophores had opposing effects on cefiderocol susceptibility: pyoverdine prevented
cefiderocol killing, while pyochelin sensitized PA to cefiderocol killing. While the discovery of cross-protective
resistant cpxS mutants was troubling, fitness testing showed that cpxS mutants paid significant fitness costs
which could lead to the extinction of cpxS strains in drug-free conditions. The central hypothesis of this proposal
is that siderophores and fitness costs linked to siderophore production can be coopted to improve
cefiderocol potency and limit the development of cefiderocol resistance. The three specific aims of this
proposal will investigate 1) CPX-mediated cefiderocol cross-protection mechanisms, 2) Mechanisms
driving siderophore-mediated cefiderocol sensitization, and 3) Test cefiderocol cycling to reduce
resistance development. In the first aim we will determine how different cpxS variants affect efflux pump
expression and siderophore production in PA, and how this in turn affect cross-protection of susceptible wild-
type PA by cpxS variants. In the second aim, we will determine how pyochelin sensitizes PA and related
Burkholderia species to cefiderocol killing. In the third aim we will use modeling to predict and test how fitness
costs paid by cefiderocol resistant strains can be used to cycle cefiderocol treatment and reduce resistance in
vitro in a hollow fiber infection model and in vivo in a CF mouse infection model. Altogether these studies will
reveal key mechanisms driving cefiderocol cross-protection and inform cefiderocol therapy might be optimized.

Public health relevance
PROJECT NARRATIVE Cefiderocol is a new trojan-horse antibiotic with potent efficacy against multidrug resistant bacteria; however, in some cases cefiderocol treatment fails. We have recently identified 20 different Pseudomonas aeruginosa gene mutations that lead to cefiderocol resistance, including some mutations that allow resistant bacteria to cross-protect cefiderocol susceptible bacteria. The goals of this research are to determine how resistance mutations work to prevent cefiderocol killing and enable cross-protection, which will help improve the usage of cefiderocol treatment.